Research Administration Core, Human DNA Samples Bank, Animal Models, & Databases

PROJECT A PI: Emmanuel Mignot Title: Research Administration Core, Human DNA Samples Bank, Animal Models, &Databases Description (provided by applicant): A seasoned and well-trained research administration staff is essential for the effective management of a complex multi-disciplinary program project. During the last consecutive 18 years of funding of this program project the Principal Investigator and the Assistant Director of the Sleep Research Center have worked together and built a team of research administrators and research support staff that are responsible for the day-to-day activities of managing the Center for Narcolepsy. This includes budgetary and fiscal reporting planning, oversight of policy and guidelines, animal and human database management, subject recruitment and the integration of this project into the Sleep Research Center and Sleep Clinic, and in general ensuring that the program runs smoothly. To support this revised research proposal, five main core activities are recognized: 1) A research administrative and coordinating function to facilitate the research &interactions among investigators and projects 2) Management of the Stanford University Center for Narcolepsy animal colonies used in this proposal;this includes zebrafish, mice, and rats. 3) Recruitment of human narcolepsy patients for research projects: this includes the banking of DNA, serum, cerebrospinal fluid and brain specimens from narcolepsy and control subjects. 4) Maintenance of computerized databases containing human, mouse/rat, canine narcolepsy data and tissue sample data;maintenance of the project's website and data-sharing on-line. 5) Maintenance of all documentation supporting adherence to all federal guidelines and policies for conducting research. It is the responsibility of the Principal Investigator to assure that the Center for Narcolepsy scientists work as an integrated team. His direction and scientific leadership, is essential to the pursuit of the overall goals of the program. A weekly research meeting is held to facilitate communication among the investigators and between the research staff and research administration staff.